Harmonization of Cross-National Studies of Aging to HRS (NIA)

Project Summary
Many cross-national studies based on the HRS family of studies have yielded new insights about aging
behaviors and health disparities around the world. This project will continue to support the development of new
international studies with harmonized HRS around the world (ATW) data. The project will also maintain
harmonization and data development among existing comparable HRS studies and foster a cross-country
research agenda. There are a number of aims consistent with that objective. First, we will organize in-person
and virtual harmonization meetings that will bring together the principal investigators and study teams of all
HRS-family surveys and relevant content experts in the field. The purpose of these meetings will be to improve
harmonization among the existing HRS surveys; to support the development of new HRS-like surveys; and to
develop a strategy for further innovations to the HRS family of surveys. Second, we will support small-scale
pilots and organize research conferences that will bring new innovations in survey contents or methodology
into the HRS network of studies, and be open to researchers outside of the network. Third, we will foster the
development of the new studies in the HRS network so that they can launch their studies successfully and with
good comparability to the more mature existing HRS ATW studies. Finally, we will support a within group sub-
network involving Brazil, India, China, and South Africa (BRICS) to conduct joint studies and seek financing
from their countries to conduct joint research and enhance study content. We intend to share reports
summarizing key discussions at the harmonization meetings, the results of small-scale pilots, and journal
articles and other research products deriving from the Network’s activities through the HRS ATW website. We
will promote these contents through our Network members, population-center networks, and professional
associations, using multiple platforms.

Public health relevance
Project Narrative The goal of this application is to continue our project that facilitates the research network for “Harmonization of cross-national studies of aging to the Health and Retirement Study.” This network supports the development of new international studies with harmonized HRS around the world data, maintains harmonization and data development among existing comparable HRS studies, and fosters a cross-country research agenda that can provide important insights for understanding health disparities.